Administrative Core

PROJECT SUMMARY
The purpose of Northern Arizona University’s (NAU’s) Southwest Health Equity Research Collaborative
(SHERC) Administrative (Admin) Core is to ensure that research and career enhancement in health equity
continue to grow at NAU. The specific goal of the Admin Core is to create a framework where the individual
core components are working together efficiently and effectively. The Admin Core will achieve this goal by
continually and carefully monitoring SHERC component activities. The primary functions for the Admin Core
will be to: prioritize activities in all cores; set and maintain common understanding of SHERC aims and
objectives; meet or exceed project milestones, and document progress against benchmarks; coordinate and
keep all cross-core activities and functions “on time and on budget”; and continuously improve individual core
and cross-core products and outputs through feedback and recommendations for improvement. As such, the
Admin Core will continue to promote shared vision, goals, and outcomes; allocate and oversee all SHERC
resources; establish and maintain community and institutional partnerships; integrate the expertise of the
Advisory Committee and cores; schedule meetings and other activities essential to the success of SHERC;
identify and support key personnel and the health equity research conducted at SHERC; evaluate SHERC’s
progress in research and institutional capacity building; and oversee all other Center activities. Overall, the
Admin Core’s responsibility will be to ensure that SHERC keeps its efforts focused on the goals of the
program. These goals include development of an impactful research center and development of research
programs that will partner with American Indian, Hispanic/Latinx, and other health disparity populations in
Arizona and across the southwestern United States (US). To accomplish these goals, we will: establish
community-engaged priorities and strategic plans for addressing a wide range of health disparities; provide the
institutional infrastructure for SHERC targeted research projects; and find creative ways to disseminate
information and best practices at the individual, community, institutional, and national levels. These strategies
present opportunities for effective engagement with a wide range of community partners, and across a wide
spectrum of individual, community, and institutional needs for focused health equity research efforts. The
Admin Core’s Specific Aims are to: (1) Continue to build and sustain the leadership infrastructure of SHERC at
NAU; (2) Strengthen and maintain an effective collaborative of community, institutional, organizational, and
government partners; (3) Develop and expand the ability of SHERC investigators to participate in team science
and translational approaches in health equity research in Arizona and the southwestern US; and (4) Build and
maintain an interactive, comprehensive evaluation feedback system to support data-driven decision making for
program improvement and innovation.